Systems Biology of Tumor-Immune-Stromal Interactions in Metastatic Progression

ABSTRACT/SUMMARY – Overall
Distant metastasis is the primary cause of cancer-related death. To colonize distant tissues, cancer cells must
migrate while evading elimination by the immune system. Evidence suggests that key steps in the induction
process of immune tolerance occur early in the metastatic cascade, located at the regional lymph nodes proximal
to the primary tumor site. However, the nature of the interactions between malignant, immune and stromal cells
remains poorly understood, including those that involve metastatic cells within the lymph nodes. Even though
lymph nodes are in fact commonly assessed in cancer patients to determine disease stage and treatment plan,
they are understudied in the context of metastatic progression. To fill this scientific knowledge gap, we propose
a Research Center to unravel the role of lymph nodes in metastatic progression. We have established that lymph
node metastasis constitutes an essential, first step in the metastatic cascade of cancer progression. We have
found that such metastases act locally upon the adaptive immune system within the lymph nodes to begin to
induce systemic tolerance of the tumor. We will further explore this new paradigm of metastases in two
malignancies, head and neck cancer and lung adenocarcinoma, by focusing on the kinetics and spatiotemporal
changes at the primary tumor, lymph node and distant sites, associated with the onset and progression of
metastasis. We have assembled a multidisciplinary team whose coordinated efforts will involve the application
of genomic and single-cell in-situ imaging technologies on preclinical and human samples to explore the
evidence and mechanisms of the induction of immunosuppression in the lymph nodes. We propose two
Research Projects that focus our scientific theme on lymph node metastasis by analyzing kinetics in a mouse
model (Project 1) and spatial temporal changes in samples of lymph nodes and their concurrent primary tumor
(Project 2), inter-connected through integrative computational analyses. Both projects will utilize a shared
resource core dedicated to the acquisition of patient samples and associated clinical annotation and data
management (Biospecimen Core and Data Core). These efforts will yield highly multiplexed, multi-scale datasets
which will be analyzed by novel bio-computational methods to reconstruct intracellular and intercellular molecular
interaction networks in order to identify, then functionally validate, critical mediators of metastasis. Our ultimate
objective is to advance our understanding of the systemic consequences of lymph node metastases and identify
new biomarkers and therapeutic approaches. Our Research Center is also dedicated to promoting our early
investigators as the next generation thought leaders applying principles of systems biology to the study of
metastasis. Our Outreach Core activity will ensure that our Research Center’s scientific and methodological
advances in applying the principles of cancer systems biology toward the study of tumor-immune-stromal
interactions are fully disseminated in the cancer research and broader communities.

Public health relevance
NARRATIVE – Overall Metastasis of tumor cells from the primary to distant sites is the primary cause of cancer -related death. We aim to identify mechanisms of metastasis in which tumor cells instruct immune cells and other stromal cells to tolerant them by focusing on the understudied role of lymph node invasion in tumor-mediated immunosuppression. Our findings promise to provide critical insights into blocking metastatic progression and thereby preventing cancer-related deaths.